Linking Science, Mathematics and Literacy

Linking Science, Mathematics and Literacy (LSM&L) ABSTRACT The proposed program will provide innovative educational resources to help redress significant nationwide deficits in science, mathematics, and literacy learning, especially for grades 6-8 students with disabilities (SWD). These new resources will improve and extend the: 1) multimodal STEM text sets: 2) virtual teacher professional development – communities of practice (vPD-CoP); and 3) scenario-based assessments (SBAs) of scientific argumentation developed by the current NIGMS/SEPA Linking Science and Literacy for Learners program, and that have garnered state and national recognition. Multimodal STEM text sets (1) are coherent collections of content and instructional resources pertaining to an anchor phenomenon and line of inquiry that support learners’: a) Engagement with a grade-band level complex anchor text; b) Development of the science and disciplinary literacy skills called for by the shared Next Generation Science Standards (NGSS) and Common Core State Standards (CCSS) or state equivalents. The vPD-CoPs (2) help teachers, learn about, develop, and implement multimodal STEM text sets for their grade 6-8 learners. The SBAs (3) provide quantitative data about the instructional interventions and help teachers understand scientific argumentation practices and include them in their instruction. Preliminary evidence supports the hypothesis that appropriate instructional support with multimodal STEM text sets, helps students (particularly SWDs) engage with grade-band level complex anchor texts and improve scientific argumentation skills that can be measured with SBAs. The proposed program will add mathematics and research-generated data to all the program resources, and the effects will be rigorously tested over five years with quantitative data from thousands of students nationwide, and with qualitative data of instructional implementation by teachers of science, mathematics, English language arts and special education in school settings, nationwide. These resources and the research data will be disseminated widely by the program website, in high profile journals, in books and reports, and at regional and national meetings, to have a lasting impact upon students’ participation in the biomedical workforce and contributions to society. The program faculty and consultants are experienced educator/researchers in science, literacy, mathematics and special education with a strong independent evaluation team and institutional support.

Public health relevance
Linking Science, Mathematics and Literacy (LSM&L): This project is focused on developing educational resources—multimodal STEM text sets—designed for middle school students to engage in and understand complex text. We will test the hypothesis that these resources, situated in life sciences topics, will result in improved learners’ reading, mathematics, and scientific argumentation skills. These resources along with findings from the project will be disseminated widely and contribute to NIH’s and the nation’s overarching goal to “enhance the training of a workforce to meet the nation’s biomedical, behavioral and clinical research needs and especially of students from underserved communities.”